Translate Membrane Structure Into Protein Functions.

Abstract
Membrane geometry is generated and maintained by the interplay of protein-lipid and lipid-lipid interactions.
Detection and remodeling of membrane shapes are part of many essential cellular processes. Furthermore,
an increasing number of proteins have been found to depend on specific membrane geometry for their function
(e.g. ArfGAP1 and Atg3) and localization (e.g. SpoVM). We are investigating the structural and molecular
mechanisms for the recognition of membrane geometry and for the translation of membrane geometry
into protein function. While pursuing these goals, we are developing innovative tools for the study of
geometry-sensitive molecules in native-like environments using spherical nanoparticle supported lipid
bilayers and membrane vesicles directly isolated from cells with an in situ NMR spectroscopy.
Autophagy is a conserved stress-response pathway in eukaryotes. De novo formation of autophagosomes to
engulf cargos targeted for degradation is the hallmark of autophagy. This process is membrane-remodeling
intensive and requires over 30 proteins, but how their actions are spatially and temporally coordinated is a
major knowledge gap. Atg3 catalyzes a direct covalent conjugation of LC3 to the amino group of phosphatidyl-
ethanolamine (PE) lipid. The conjugate LC3–PE triggers phagophore expansion and acts as an adaptor for
sequestering cargos for breakdown. Our study has revealed that selective binding of human Atg3 (hAtg3)
to highly curved membranes is tightly linked to its conjugase activity via a multifaceted membrane
association mechanism. In this system, the highly curved membrane functions like a classical E3
ligase by bringing substrates (Atg3–LC3 and PE lipids) into proximity and priming the active site of
Atg3 for catalysis. These results have made major contributions to establishing and advancing the
concept that the distinct membrane structure of the cup-like phagophore spatiotemporally regulates
autophagosome biogenesis. We are determining the structural and molecular basis of how the multifaceted
membrane association of hAtg3 coordinates its curvature sensitivity and conjugase activity to promote LC3–PE
conjugation only on the target membrane in the context of the putative E3-like Atg12-Atg5/Atg16 complex.
My collaborator, Dr. Wang, has recently discovered that phagophore closure requires a subset of ESCRT units
including VPS37A, CHMP2A, and Vps4. ESCRTs mediate membrane remodeling and scission throughout the
cell. We have demonstrated that recognition of highly curved membranes by two hydrophobic motifs
in the VPS37A is essential for its phagophore localization and autophagosome closure. We are
investigating how the VPS37A UEVL domain, in conjunction with the two membrane binding motifs,
orchestrates the spatiotemporal process of autophagosome closure. Results from our study will provide the
necessary foundation for continued analyzing the poorly understood biogenesis of the autophagosome during
autophagy and, moreover, shed lights on the interplay between membrane structure and protein function.

Public health relevance
Project Narrative Cellular membranes exhibit diverse and dynamic shapes to facilitate many essential cellular processes such as endocytosis, vesiculation, and cell division. The entry of bacteria and viruses into human cells also requires altering membrane shapes. Therefore, understanding the molecular basis for interdependence of membrane structure and protein function is a fundamental biological question. We have chosen two human autophagy proteins, hAtg3 and VPS37A, as primary examples in the present study. The process of autophagy depends on the ability of Atg3 and VPS37A to specifically interact with the target membrane for constructing double- membrane vesicles called autophagosomes. However, the spatial and temporal regulation of the autophagosome biogenesis remains poorly understood. Our proposed research addresses this question with the hope of revealing new avenues for treatments. Autophagy is an emerging therapeutic target in multiple diseases such as neurodegeneration, infection, cardiovascular impairment, and tumorigenesis.